Protecting and Sustaining Germ Cell Identity

Project Summary/Abstract
Germ cells have the extraordinary potential to generate every cell type in the body. Yet, the molecular program
that protects and sustains this promise for totipotency in germ cells, which can last more than forty years in
humans, is poorly understood. To face this challenge, germline regulators assume dual roles in maintaining germ
cell identity: activating a germline transcriptional program while simultaneously protecting germ cells from
reprogramming to a somatic cell fate. Indeed, genes involved in germline specification, such as the conserved
RNA-binding protein Nanos and the transposable element (TE) regulator Piwi, are erroneously upregulated in
certain human tumors. These tumors are thought to undergo soma-to-germline transformations to acquire a
more immortal, germline-like state. However, a specific program for germ cell transcriptional activation has yet
to be described, mainly because a ‘master-regulator transcription factor’ for germ cell fate is missing. This
proposal uses a multipronged approach to systematically characterize the gene expression program in primordial
germ cells (PGCs) and identify prime regulators of germ cell fate. The goal is to distinguish between a ‘default’
model, by which repression of the somatic program ‘allows’ the PGC program, and an ‘instructive’ model, by
which PGC specification is actively controlled. In Aim1, we probe the instructive model to uncover the germline
transcriptional program. By single-cell RNA sequencing, we have detected specific, temporally-regulated
germline genes. To identify the transacting regulatory factors, we will use ATAC-sequencing, characterize known
factors with matching binding activities, and identify potential new regulatory candidates for germline genes. In
Aim2, we address the function of a critical regulator of germ cell fate, the conserved RNA regulator Nanos. Using
the RNA target identification method hyper-TRIBE and ribosome profiling, we will identify Nanos targets and
functionally distinguish between those targets that promote the germline program and/or repress the somatic
program. Aim3 focuses on the piRNA pathway, which provides maternally inherited immunity against TE activity
by controlling the transcription of TE elements, specifically in germ cells. Using a novel degradation strategy to
specifically degrade components of the piRNA pathway in PGCs without impacting oogenesis, we will determine
the role of this pathway for embryonic PGC gene expression beyond TE control. By integrating multiplex findings,
this proposal will uncover the regulatory landscape of early germ cells, thereby providing a necessary
understanding of the process of gonadogenesis and, ultimately, the survival of the species.

Public health relevance
Project Narrative Germ cells must maintain their identity for the entirety of a species' reproductive lifespan, a task that can last up to forty years in humans. This unique challenge raises the question: What underlying molecular processes govern germ cell identity and prevent reprogramming toward a somatic cell fate? A multiplex approach proposes to answer this question by (i) identifying factors that are instructive for the germline genetic program, (ii) uncovering how the translational repressor Nanos protects germ cell fate and prevents germline to soma transformation, and (III) addressing the role of small RNAs in germ fate specification and genome protection.